Bioorganic Approaches Toward Novel Antimicrobial Agents and Chemotherapeutics

Project Summary / Abstract
The goal of our laboratory is to interface challenging and thought-provoking organic chemistry
with issues of plausible biological application. A primary goal for the next five years is to develop
new molecular probes and leverage these molecules to advance our understanding of human
disease. Critical to the role which the laboratory plays at Vanderbilt University, and within larger
concerns of glycobiology, is problem selection. On the chemistry side, we identify problems of a
complexity level conducive to new and significant learning experiences. At the level of biology,
we select difficult problems that may be subject to accelerated advance if the necessary chemistry
can be developed. Taken together, the overall vision for our program is to apply a human health
driven approach to developing robust and reproducible reactions and synthesis strategies to
interrogate clinically relevant diseases.

Public health relevance
Project Narrative The proposed research is relevant to public health because of the need to develop and study new treatments for resistant bacterial infections and aggressive cancers. Carbohydrates and their conjugates are present on the surface of all cell types and are key transmitters of biological information. This proposal addresses the synthesis, modification, and evaluation of carbohydrates that have potential to be used as novel treatments for human disease.